GERMLINE SEX DETERMINATION

The first developmental choice faced by germ cells in the majority of higher eukaryotes is oogenesis versus spermatogenesis, but very little is known about how this basic event is genetically encoded in any organism. We have chosen to study the developmental genetics of this germline sex determination process in the fruit fly, Drosophila melanogaster. Our long-term goals are to: 1) identify the major germline sex determination regulatory genes, 2) determine how they are related in terms of a developmental hierarchy and 3) understand in detail how these regulatory gene products function. We are question oriented and take advantage of genetic, molecular, and biochemical techniques as needed. Current molecular studies are focused on OVO, a highly conserved zinc-finger domain protein functioning at an essential intersection in the hierarchy. The study of OVO is broadly relevant as ovo mutations in mice and flies appear to result in very similar phenotypes. A standard model for regulated transcription holds that regulatory proteins bind enhancer and silencer sequences and influence the expression from a basal core promoter bound by ubiquitous transcriptional machinery. Interestingly, OVO protein binds to an enhancer and to a core promoter element of the downstream ovarian tumor locus. We have now definitively shown that both the upstream enhancer and the core promoter sites are functional by using reporter genes. We suggest that OVO acts as a tissue-specific transcription factor at both the expected enhancer location and at the core promoter. We are currently testing a number of core promoters to determine what subset of core promoters (-30 to +30) will respond to OVO enhancers. OVO can act as both a transcriptional activator and as a transcriptional repressor at ovarian tumor. We have shown that two families of OVO proteins, OVO-A and OVO-B (positive) and OVO-A (negative) have opposing activities in flies, both in terms of transcription and in terms of phenotypes. Interestingly, OVO-A and OVO-B have thematically similar opposing activities in yeast one-hybrid experiments, suggesting that OVO proteins interact with transcriptional components conserved in yeast. We are also beginning experiments to determine how OVO influences the binding of other proteins involved in transcriptional initiation. Future work on OVO will be focused on how OVO-B versus OVO-A isoforms are regulated and on the downstream targets of OVO function.